Establishing Human 2D and 3D Testicular Models to Elucidate Monkeypox Virus Tropism and Pathogenic Mechanisms in the Testes

ABSTRACT
One of the most important lessons learned from the recent global outbreak of the monkeypox virus, now called
Mpox virus (MPXV, clade II), is the recognition that males are at a much higher risk for infection and higher
occurrence of genital rash. Transmission via sexual contact is one of the main routes of virus spread. However,
whether MPXV constitutes a sexually transmitted infection and can infect the male reproductive tract is still
being debated, thus affecting the strategies to minimize transmission risk. Confirmed reports of MPXV
shedding in seminal fluid for long after the clearance of viremia suggest the ability of MPXV to establish a
productive infection in genitourinary organs. Poxviruses can also cause testicular complications, including
azoospermia and seminiferous tubule atrophy. More recently, MPXV antigens have been detected in the testis
of nonhuman primates both during the acute and convalescent stages, and the presence of testicular
inflammation and necrosis in these macaques collectively suggests testis-tropism of MPXV, like Zika and Ebola
viruses. However, direct evidence of MPXV infection in human testis is currently lacking, including cell targets
of the virus and downstream consequences. Relevant human in vitro models are needed to characterize MPXV
testicular infection. Human testis immune homeostasis is tightly governed by an elaborate communication
network between different cells including testosterone-producing Leydig cells (LC) and Sertoli cells (SC) that
form the blood-testis barrier (BTB). We recently established a 3D human testicular organoid (HTO) system
comprised of undifferentiated spermatogonia cells, SC, LC, and peritubular myoid cells that closely
recapitulates the cell diversity and function of the human testis to study Zika virus and SARS-CoV-2 infection.
We have also established 2D cultures of primary SC, LC, and mixed seminiferous tubule cells and an in vitro
BTB model to delineate cell-specific responses to viruses. Therefore, the goal of this study is to utilize our 2D
and 3D testicular culture systems as an effective in vitro surrogate to model testicular infection of MPXV and
understand downstream consequences. In Aim 1, we will assess MPXV infection in the 2D and 3D HTOs,
identify cell targets, and characterize key infection pathologies, including cytopathic effects, antiviral response,
and effect on BTB integrity. Aim 2 will utilize single-cell RNA sequencing to determine relative infectivity in
each cell type and key pathways, including antiviral and inflammatory response, cell death, and
spermatogenesis. Collective data will provide much-needed evidence of the testis as one of the target organs
of MPXV replication after it is cleared from blood and skin lesions and lay the foundation for future in vivo
studies of transmission via the sexual route. The knowledge of whether MPXV is a sexually transmitted
infection is critical in providing clinical management and transmission guidelines, especially in men who have
sex with men (MSM), an underrepresented group in biomedical research.

Public health relevance
Establishing Human 2D and 3D Testicular Models to Elucidate Monkeypox Virus Tropism and Pathogenic Mechanisms in the Testes Narrative The recent emergence of monkeypox clade IIb (MPXV) in the USA, primarily afflicting men, and lack of therapy prompts urgent investigation into its potential as a sexually transmitted infection. This proposal aims to elucidate MPXV's testicular tropism and pathogenesis using advanced human testicular organoid models, offering insights critical for therapeutic development and public health strategies.